NIAAA Short-Term Training: Students in Health Professional Schools

Project Summary/Abstract The Yale School of Medicine has a long tradition and record of accomplishments in the training of medical students for careers in academic medicine and research. This application is a resubmission requesting NIAAA support for medical students (NIAAA Short-Term Training: Students in Health Professional Schools) to carry out research primarily with NIAAA funded investigators. The purpose of the grant application is to provide intensive short-term training in research for selected pre-doctoral medical students in the most outstanding laboratories and training sites in the Yale School of Medicine. The specific research experiences will include social, behavioral, biological, and mathematical sciences as related to alcohol abuse and alcoholism. The initial application received an impact score of 41. The program is designed to attract the most highly qualified Yale medical students into careers as physician-scientists in the biomedical sciences. An extensive follow-up documents a high level of subsequent research training, research productivity, and faculty appointments (40.2%) among previously supported students. Trainees will be chosen upon application of pre-doctoral medical students who have completed in good standing one year of the curriculum of the Yale School of Medicine. Eight (8) students per year will be selected competitively for this short-term training support on the basis of the quality of a formal written proposal of the planned research and the quality of the mentor and the training environment. The participating departments and sections will include: psychiatry, cell biology, cellular and molecular physiology, genetics, molecular biophysics and biochemistry, pharmacology and related interdisciplinary centers.

Public health relevance
Project Narrative The purpose of this training grant to provide intensive short-term training in research areas of interest to NIAAA for 8 selected pre-doctoral medical students in the most outstanding laboratories and training sites in the Yale School of Medicine. The specific laboratory experiences will range from fundamental molecular biology, cellular and organ physiology to applied clinical research. The program is designed to attract the most highly qualified Yale medical students into careers as physician-scientists in the biomedical sciences in areas of interest to NIAAA.